CD4+ T cell Immunity in the Respiratory Tract

Abstract
Pneumonia remains the #1 killer of children in the world and is a leading cause of morbidity and
mortality in children in the US and the #8 cause of mortality in adults. Our laboratory has made
seminal insights in mechanisms underlying host defense against extracelluar pathogens –
particularly in the area of type 17 cytokines –IL-17 and IL-22, and tissue resident memory CD4+
T cells. Using murine and primate respiratory tract samples we will assess the metabolic
requirement of lung and nasal TRM cells and investigate if antigen exposure is required for lung
term survival. We have previously shown these cells occupy a unique submucosal niche and
require IL-17RC signaling in fibroblasts for function. We will determine if there are feedback
loops between fibroblasts and T cell to maintain these cells and if lung TRM cells epigenetically
modify lung fibroblast populations. The research proposed under this R35 will shed new light
on pulmonary host defenses that can be exploited to reduce the global burden of pneumonia
mortality and morbidity.

Public health relevance
Narrative Pneumonia remains the #1 killer of children in the world and is a leading cause of morbidity and mortality in children in the US and the #8 cause of mortality in adults. This proposal will conduct research to better understand host resistance against pneumonia that can be used to develop new therapies or vaccines to prevent or treat pneumonia.